Modeling schizophrenia with patient-specific mutations in GRIN2A and SP4

PROJECT SUMMARY: Schizophrenia (SCZ) is a common and debilitating mental illness characterized by
positive symptoms, negative symptoms, and impaired cognition, with a lifetime prevalence approaching 1% in
the United States. Unfortunately, progress in understanding the etiology and pathophysiology is hindered by
the lack of appropriate models that adequately capture both the complex and heterogeneous nature of the
genetic risk and the diversity of the phenotypic manifestations. The advent of induced pluripotent stem cell
(hiPSCs) technology provides an important new platform to study the cellular and circuit behavior of human
cells that contain an individual’s full complement of primary sequence risk alleles. Thus, the door is now
opened to developing improved in vitro models that can enhance our understanding of etiology and
pathophysiology in an integrated context, relating patient genomes to their cellular phenotypes. Here, we
propose to generate novel hIPSC lines harboring patient-specific mutations in two highly penetrant SCZ risk
genes, GRIN2A and SP4. GRIN2A encodes a subunit of the N-methyl-D-aspartate receptor (NMDAR) which
are a subclass of ionotropic glutamate receptors that play a pivotal role in the development, plasticity, and
pathophysiology in the central nervous system. NMDAR hypofunction is a leading causal hypothesis for SCZ
because subanesthetic doses of the NMDAR antagonists produces acute psychosis in healthy subjects. In
addition, autoimmune encephalitis due auto-immunoreactivity to NMDARs leads to severe psychosis. SP4
belongs to the SP1 family of transcription factors that recognizes DNA sequences termed GC-boxes that are
often found upstream of transcription start sites (TSS). SP4 has been shown to functionally regulate the
expression of NMDARs through direct interactions with GC-boxes upstream of the TSS of GRIN1, GRIN2A,
and GRIN2B. In addition, Sp4 hypomorphic mice have reduced hippocampal long-term potentiation, reduced
NMDAR expression, and behavioral abnormalities related to SCZ. Importantly, both GRIN2A and SP4 are high
priority SCZ risk genes, being associated with SCZ through genome-wide association studies and rare variant
analysis. We propose to use CRIPSR editing to generate patient-specific mutations in GRIN2A and SP4 with
consideration of the genetic background of the hIPSC lines. Both genes will be individually edited in the same
six control hiPSCs lines with elevated SCZ polygenic risk scores. We will perform quality control experiments
to confirm mutations are correct and no off-target mutations are present. Validation of functional mutations will
be confirmed with qPCR, Western blot and electrophysiology. Once validated, we will quantify the effect of
these mutations on spontaneous network activity using multi-electrode arrays and their effect on the
transcriptome with RNA sequencing. The overall goal of this proposal is to develop novel cellular models of
SCZ that can inform us about pathophysiology and help identify convergent molecular mechanism in SCZ with
the goal of identifying therapeutic targets for this debilitating disorder.

Public health relevance
PUBLIC HEALTH RELEVANCE/NARRATIVE Schizophrenia is a common and debilitating mental illness with relatively unknown etiology or pathophysiology. We are proposing to generate patient-specific mutations of known schizophrenia risk genes in induced pluripotent stem cells. We will then use electrophysiology, cell biology, imaging, and molecular analyses to study human neurons derived from these stem cells to discover pathophysiology associated with these mutations with the goal of developing new therapeutic treatments.